TAS::75 0893::TAS E-TECHNOLOGY TOOLS FOR EXTENDING THE REACH OF PREVENTION INTER

The overall objective of the proposed research is to determine the technical feasibility of a web-based media literacy substance use prevention program for use with families and their elementary school children, called Media Detective Family (MDF). MDF will be based off of the existing in-person program called Media Detective Parent Night (MDPN).